Inhibition of autoimmune diabetes by ST8Sia6

Abstract
Autoimmune diseases can occur in nearly any part of the body, and pose a significant problem in
human health, including both systemic autoimmunity and tissue-specific autoimmunity. 1.25 million
Americans have type 1 diabetes (T1D), where the immune system destroys insulin-producing beta cells.
Although exogenous insulin can control blood glucose levels in patients with diabetes, glucose homeostasis
is difficult to maintain and serious long-term complications including nephropathy, retinopathy, and peripheral
neuropathy are far too common. Since the first procedure using the Edmonton protocol in 1999, islet
transplantation has established itself as a promising therapy for patients with longstanding T1D, and beta cell
replacement using replenishable sources like human embryonic stem cell-derived beta cells has the potential
to become curative. Islet transplantation requires a drug regiment to suppress the immune response from
allorejection as well as autoimmune attack against pancreatic b cells, resulting in chronic immunosuppression
with its own severe complications, exposing patients to risk of infection and malignancies. Immunotherapies
that provide local inhibition of immune response to the graft, without systemic immune inhibition, are a critical
need. Immune cells have receptors that can either activate or suppress an immune response. Sialic acids
incorporated into glycans have the ability to bind to a family of predominantly inhibitory receptors on the
surface of many immune cells. We have shown that the sialic acid transferase ST8Sia6 generates ligands for
the inhibitory receptor Siglec-E, which is expressed on innate immune cells. In addition, our work
demonstrated that ST8Sia6 expression on tumor cells leads to enhanced growth and protection from the
immune response. Here, we generated a novel line of mice in our laboratory where ST8Sia6 is constitutively
expressed in pancreatic b cells in the NOD mouse model of Type 1 diabetes (“NOD bST mice”). NOD bST
mice are strongly protected from the development of diabetes; only 6% of NOD bST female mice became
diabetic as compared to 60% of NOD female littermate controls. Strikingly, NOD bST mice possessed a
durable tolerance towards b cells, as protection was maintained after ST8Sia6 expression was inhibited with
doxycycline. The focus of this proposal is to understand the changes in the immune response that occur with
ST8Sia6 expression in b cells, and whether ST8Sia6 expression on b cells provides enhanced protection
from immune attack after transplantation. By doing these experiments in mice, important information will be
gained that may be translated to the clinic for islet replacement therapy for patients with T1D.

Public health relevance
Project Narrative Approximately 1.25 million Americans have Type 1 Diabetes, where the immune system targets insulin- producing b cells within the islets of Langerhans for destruction, and there is no cure as we do not know how to stop this immune-mediated attack. We have generated a novel mouse model in which the sialic acid transferase ST8Sia6 is expressed in b cells in NOD mice, which reduces the incidence of diabetes by 90%. The focus of this proposal is to examine the changes in the immune response which protect pancreatic b cells from immune-mediated attack in this model, and to determine if this improves efficacy of islet transplantation.